Use of a Powered Orthotic Exoskeleton to Promote Mobility Through Improved Squat, Knee Flexion and Loading of the Paretic Leg in Persons with Chronic Stroke

Ninety percent of stroke survivors have clinically significant gait impairments that lead to secondary
medical complications, including cardiovascular deconditioning and reduced quality of life (QOL). Several
rehabilitative interventions that increase the level of activity and mobility have been shown to be beneficial.
Challenges posed by most of these locomotor gait training interventions require recurring visits to a
rehabilitation center. The recent development of novel powered exoskeletons offers a potential mechanism for
stroke survivors to improve mobility in the home and community. Although the predominant research using
these devices have been in persons with spinal cord injury, there are currently two devices approved by the FDA
for use in patients with stroke and additional devices are being developed. The Keeogo powered orthotic
exoskeleton is a novel device intended for persons with stroke who can ambulate but have gait impairment. This
device consists of a ridged orthotic structure placed over clothing on the legs and batteries to the power motors
that assist both knees in gait movement. The system monitors hip movement driven by the user and interprets
this movement to apply the appropriate assistance at the knee joint. This unique approach makes learning
intuitive, enabling the user only to acclimate to the system rather than learning how to control the device to
initiate the desired movement.
This proposal is a randomized controlled pilot study. Fifteen veterans with chronic stroke (>6months)
and who retain some ability to take steps but have impaired gait will be recruited. Ten participants will be
randomized into the exoskeleton group and 5 into the control group. Both groups will be asked to complete 36
one-hour sessions of ambulation training. The exoskeleton group will train using the Keeogo powered orthotic
exoskeleton and the control group will train without using their own conventional aide.
The primary aim is to determine the efficacy of training with this exoskeleton and its ability to improve
transfers to standing and sitting as assessed by the five times sit-to-stand test. A secondary aim will be to assess
effects of the device during overground ambulation. Outcome measurements to investigate changes of knee range
of motion and loading of the paretic limb will be accomplished using an instrumented goniometer; changes in
limb loading will be monitored using a foot pressure mapping system; and stepping parameters will be recorded
using the GaitRite carpet. An exploratory outcome of changes in energy expenditure during ambulation with and
without the powered exoskeleton will be assessed from a 6-minute walking test using a portable metabolic cart.
Additional exploratory outcome measures of QOL will be determined using the SF-36 and the Stroke Specific
Quality of Life Scale.
Baseline testing for both groups will be performed while ambulating without the device and prior to
starting in the training program. The exoskeleton group will repeat testing within the first 3 sessions of the
training program. Post assessments will be obtained after 36 sessions of training. Retention will be assessed by
repeating the assessments without the exoskeleton after 1 month of stopping the training program.
It is anticipated that longitudinal training with the device will increase number of squats achievable,
increase knee flexion during swing, increase loading of the paretic limb, and induce symmetrical stepping. No
immediate effect on energy expenditure by the device is expected however, a training effect is expected to
demonstrate improvement in the energy cost of ambulation. Any gains observed during this study may not be
retained, but as this device has the potential to be used in the home and community environment, justifying a
prescription of this device for retention purposes may be warranted. Use of this device may also lead to
improvement of QOL.

Public health relevance
Veterans who suffer strokes often have disturbances in the ability to walk that reduces independence and quality of life. Alterations in gait combined with general decreased activity are associated with reduced muscle strength of the paretic leg. This leads to cardiovascular deconditioning and reduced quality of life. There is a new and novel battery powered device (Keeogo powered orthotic exoskeleton) that uses motors that assist knee movement while walking, sitting down, and standing up. The Keeogo monitors hip movement to assist the knee, making it simple to learn how to use. If successful, this project will show how this device will help improve the ability to walk and provide evidence to support larger clinical trials in a home and community setting to improve mobility, increase muscle mass and strength in the legs, as well as improve general health and quality of life. Lastly, this device could be used to increase motivation and confidence in a person to walk for longer periods of time and distance, providing the ability to walk in places that were previously inaccessible.